DIABETES COMPLICATIONS AND CONTROL TRIAL

The first two years of this study were designed to determine the feasibility of a longer study to determine whether clinically and statistically a difference in level of blood glucose control can be achieved between standard and experimental therapy groups. This feasibility study was successfully completed in September, 1985, and the long term trial is no well underway in 27 centers. Recruitment of the 1400 patients was completed in 1989, and the study is scheduled to be completed in 1993.